Artificial intelligence for the automated detection of polycystic ovary syndrome on ultrasonography

PROJECT SUMMARY
Polycystic ovary syndrome (PCOS) affects 1 in 8 women of reproductive age imparting serious reproductive,
cardiometabolic and psychosocial health complications for patients across the lifespan. Despite a high
prevalence, under- and misdiagnosis of PCOS is common and contributes to significant delays in the delivery
of evidence-based care. Lack of standardization in the clinical evaluation of PCOS features contributes to
these delays in diagnosis. We have shown that ultrasonographic aspects of ovarian morphology have high
diagnostic accuracy for PCOS and recently provided the new international standards for defining polycystic
ovaries on ultrasonography. However, conventional assessments of ovarian morphology have moderate to
poor inter-rater reliability which impacts their performance in clinical practice. Artificial intelligence provides an
exciting opportunity to harmonize the ultrasonographic evaluation of PCOS. We propose that the use of deep-
learning approaches for image classification, segmentation, and integration with clinical and biochemical
markers can provide a framework to enable the timely detection and treatment of this highly prevalent
condition. To that end, this project will develop a model for the automated characterization of polycystic ovarian
morphology on ultrasonography (Aim 1), that can be leveraged alongside clinical and biochemical parameters
to detect PCOS status (Aim 2). Our approach involves the use of a highly unique archive of ultrasonographic
images and volumes of the ovaries garnered from well-characterized women across the reproductive
spectrum, as well as external validation of the model for PCOS status using 2-dimensional and 3-dimensional
views of ovarian morphology. The hypotheses to be tested are that a trained and externally validated deep
learning model can detect follicle excess, ovarian enlargement and/or stromal aberrations that effectively
define polycystic ovarian morphology, and that integration of one or more clinical or biochemical parameters
yields a high performing model for the classification of PCOS status. By providing a model for the automated
detection of PCOS, we expect to make important strides toward resolving subjectivity in the clinical evaluation
of PCOS. Ultimately, standardization in the diagnostic assessment is needed to obviate delays in detection and
facilitate access to treatment and prevention strategies that improve the overall health and well-being of
patients living with PCOS.

Public health relevance
PROJECT NARRATIVE Polycystic ovary syndrome (PCOS) is a highly prevalent gynecological disorder that is often misdiagnosed leading to significant distress for patients and delays in accessing evidence-based care. This project addresses the need to improve the timely and accurate diagnosis of PCOS by applying deep-learning approaches to a unique archive of sonograms, garnered from women across the reproductive spectrum, to generate a novel imaging-based model for the detection of PCOS. The demonstration that artificial intelligence can accurately predict PCOS will usher future practices that standardize the clinical evaluation of PCOS and obviate the current delays in diagnosis experienced by patients.